Lipid-Based Interventions to Mitigate the Impact of Arsenic on Microglial Function and Neurobehavior

PROJECT SUMMARY/ABSTRACT
Anxiety and depression afflict more than 548 million people worldwide. Furthermore, >20% of individuals are
refractory to conventional treatment, leading to a 2.2-fold increase in mortality risk. Importantly, individuals with
early-life anxiety/depression also show a 1.24 to 2-fold higher risk of dementia in later life, suggesting converging
pathogenic mechanisms. An incomplete understanding of these conditions is a significant barrier to improving
patient neuropsychiatric/neurocognitive health. Until recently, efforts to clarify disease etiology have centered
around genetic and social factors, often neglecting environmental drivers that are increasingly linked to
neurobehavioral dysfunction. Among the WHO’s top chemicals of public health concern, arsenic (As) is a toxic
metalloid strongly associated with anxiety, depression, and dementia. Importantly, data indicate that these
disorders have neuroinflammatory origins, with microglia serving as causal mediators. Arsenic is known to
accumulate in the brain and activate microglia. However, the mechanisms by which it contributes to
neurobehavioral dysfunction remains incompletely understood. Our lab has shown that arsenic depletes the
brain of the essential fatty acid docosahexaenoic acid (DHA). This is significant because DHA plays multiple
homeostatic roles in the brain, including effects on neurotransmission and microglial class-switching from pro-
inflammatory (M1) to anti-inflammatory (M2) states. This proposal will use a complementary array of in vivo
mouse studies and ex vivo experiments in primary microglia to interrogate our central hypothesis that DHA is
essential for protecting neurobehavioral health from arsenic toxicity, and that targeted brain DHA enrichment
mitigates environmental threats linked to anxiety, depression, and dementia. The research component of this
training grant will provide the fellow with a rigorous depth and breadth of training in a complementary array of
state-of-the-art techniques, including advanced behavioral assessments, electrophysiology, mass spectrometry
imaging, and various assays to characterize microglial biology. These technical skills will be supplemented with
highly engaged multidisciplinary mentorship and educational activities across the fields of neuroscience,
environmental health, and clinical medicine. A central goal of this integrated training plan is to empower the
fellow with skills to critically appraise, use, and analyze various models, methods, and data. Collectively, this
proposal will launch the fellow’s long-term success as a physician-scientist at the cutting-edge of environmental
neuroscience with the knowledge and skills to unlock the mechanisms of environmentally-driven neurobehavioral
dysfunction in order to improve human health and promote health equity.

Public health relevance
PROJECT NARRATIVE Emerging evidence implicates arsenic in the etiology of anxious/depressive disorders and later life dementia, effects likely mediated by microglial dysfunction. Given the tremendous gaps in treatment for these conditions, molecules like lysophosphatidylcholine-docosahexaenoic acid (LPC-DHA) that cross the blood-brain barrier and exert anti-inflammatory and antioxidant effects in microglia may offer a new avenue for improving neurobehavioral outcomes. Combining sophisticated in vivo and ex vivo research examining arsenic-induced neurotoxicity and the protective mechanisms of LPC-DHA with individually tailored educational activities, this training grant will equip the fellow for a career as a physician-scientist exploring and addressing the environmental drivers of neurobehavioral disorders.